Genetic and mechanistic analysis of carbon dioxide tolerance in Cryptococcus pathogenesis

PROJECT SUMMARY
Cryptococcus neoformans is an important cause of human fungal infections and is one of the most
common causes of infection-related deaths in people living with HIV/AIDS. As an environmental fungus, C.
neoformans must be able to adapt to mammalian physiology in order to cause disease and only a minority of
C. neoformans strains can do so. Three traits have been identified that distinguish many pathogenic C.
neoformans strains from non-pathogenic strains: 1) capsule formation; 2) melanization; and 3) the ability to
grow at mammalian body temperature. Recent studies of large collections of C. neoformans strains indicate
that these three traits do not explain the observed variation in virulence because many closely related strains
that express the three major traits still show significant differences in virulence. In the previous funding period,
we have discovered that the ability to tolerate carbon dioxide (CO2) concentrations of mammalian host is
required for C. neoformans virulence. We also identified protein kinase and transcription factor networks
involved in CO2 tolerance. Finally, quantitative trait loci (QTL) mapping and in vitro evolution of low CO2 fitness
isolates to identified modulators of CO2 fitness and revealed that multiple pathways and genes contribute to
variation in CO2 fitness. In the next funding period, we propose to determine how these virulence-associated
regulatory pathways interact to balance positive and negative responses to host CO2 stress (Aim 1). We will
also identify and characterize the downstream physiologic and cell biologic processes by which the regulatory
networks modulate CO2 tolerance (Aim 2). Our preliminary data indicate that CO2 tolerance may have
independently emerged multiple times across the Cn genomic complexes. In Aim 3, we will identify and
characterize the mechanisms through which this trait is expressed in clinical isolates with an initial focus on
loss of Rim pathway function. Our mechanistic characterization of this emerging Cn virulence trait is expected
to provide new insights into Cn pathogenesis and to identify novel pathways and targets for antifungal drug
development.

Public health relevance
PROJECT NARRATIVE Cryptococcus neoformans causes lethal infections of the central nervous system and is one of the most important causes of death in people living with HIV/AIDS. This project seeks to understand how C. neoformans adapts to the infected host with a focus on the high carbon dioxide levels in mammals compared to its normal environmental niche. In this way, we expect to identify new pathways for antifungal drug targets and better understand how C. neoformans causes disease.